TRPV1-dependent neuro-immune modulation and regulation of endogenous acyl-dopamines in sepsis and acute inflammation

PROJECT SUMMARY
Sepsis is a formidable public health problem, and there is a need to better understand the basic mechanisms
of sepsis and immunomodulation. Our studies will define the anti-inflammatory mechanisms and functional
effects in sepsis of N-oleoyl dopamine (OLDA) and N-arachidonoyl dopamine (NADA), which are endogenous
acyl-dopamines produced in the peripheral and central nervous systems (PNS, CNS). OLDA and NADA exhibit
activity at the transient receptor potential vanilloid 1 (TRPV1) and cannabinoid receptor 1 (CB1R). In mice with
S. aureus pneumonia, intraabdominal polymicrobial sepsis, or endotoxemia, we found that OLDA or NADA
administration 1) induces an early substantial upregulation of systemic IL-10, 2) decreases pro-inflammatory
cytokines and chemokines, and 3) reduces acute lung injury and sepsis scores at 24 hours. NADA also
reduces CGRP and increases Substance P in the plasmas of LPS-treated mice. Our studies in bone marrow
chimeras of Trpv1-/- and wild-type mice indicated that NADA induces IL-10 via TRPV1 expressed by non-
myeloid cells. Our further preliminary data suggest that neuronal TRPV1 mediates the anti-inflammatory and
protective actions of OLDA in LPS-treated mice, and more specifically, that these effects are mediated by
TRPV1 neurons in the CNS rather than the PNS. Finally, we observed increased plasma and brain levels of
OLDA and NADA in LPS-treated mice, which suggest that these novel endogenous lipids may be dynamically
regulated during acute inflammation and sepsis. Collectively, our data have led to our central hypothesis that
there is a CNS based neuro-immunomodulatory link that involves the activation of neuronal TRPV1 by
endogenous lipids, such as OLDA and NADA, and regulates inflammatory responses and outcomes of acute
inflammation and sepsis. Aim #1 will localize the TRPV1 neurons responsible for the anti-inflammatory actions
of OLDA and NADA in acute inflammation and sepsis and determine the role of CB1R in the TRPV1-dependent
anti-inflammatory actions of OLDA and NADA. Aim #2 will identify the downstream mechanisms by which the
activation of neuronal TRPV1 by OLDA or NADA upregulates IL-10 production by circulating monocytes in
sepsis, focusing on the roles of Substance P, CGRP, and the sympathetic nervous system. Aim #3 will define
the effects of OLDA and NADA on sepsis outcomes, and the effects of sepsis on endogenous production of
OLDA and NADA, and expression of TRPV1 and CB1R. These studies will advance the understanding of the
neuro-immunomodulatory effects and endogenous roles of NADA, OLDA and TRPV1 in sepsis, with the
ultimate goal to identify novel therapeutic targets.

Public health relevance
PUBLIC HEALTH RELEVANCE Sepsis is a life-threatening consequence of infection that can cause shock, organ failure, and death. Our preliminary studies suggest that during bacterial sepsis, links between a receptor in the nervous system, TRPV1, and cells of immune system are responsible for strong anti-inflammatory and protective effects of two lipids, N-oleoyl dopamine (OLDA) and N-arachidonoyl dopamine (NADA). We will further investigate the anti- inflammatory and protective mechanisms of OLDA and NADA, with the long-term goal to define therapeutic targets for sepsis and other inflammatory processes based on this novel neuroimmune link.